Odor-Reward Association Encoding in CA2 and its Contribution to Social Memory

PROJECT SUMMARY
Impairments in social memories are central to many neuropsychiatric disorders, including Schizophrenia
(SZD). This application investigates olfactory processing in the CA2 region of the rodent hippocampus and its
contribution to social memory—the ability to encode and recall another conspecific. CA2 is necessary for social
memory in rodents; inhibiting dorsal CA2 (dCA2) during an initial social interaction disrupts a mouse’s ability to
form and recall that social memory. But how CA2 precisely contributes to encoding and retrieval remains unclear.
Since mice rely on olfaction to investigate social targets, I hypothesize that murine CA2 is vital to the integration
and discrimination of social olfactory cues that provide valent information about different conspecifics. In a pilot
study using water-restricted female mice, I found that silencing CA2 activity with inhibitory opsins showed a trend
towards impairing the mice’s abilities to distinguish one male mouse urine from another in a head-fixed, Go/No-
Go Odor Discrimination Task, in which GO odors are paired with a water reward. Using 2-photon calcium imaging
in seven mice, a collaborator and I have discovered that dCA2 processes both social and nonsocial odors.
Moving forward, I am using 2-photon imaging to test how CA2 uses olfactory information to discriminate between
odor stimuli and to associate odors with conditioned or unconditioned valences, and how perturbation of this
processing affects social memory in disease. In Aim 1, I am identifying sex differences, if any, in CA2 function
with respect to the encoding of five odors—two naturally valent male urines (social odors), methyl butyrate and
ethyl acetate (nonvalent nonsocial odors), and a mock odor (water)—in a “three-phase paradigm” (TPP) involving
passive odor delivery before and after active odor discrimination. In Aim 2, I will compare the social and nonsocial
odor processing functions of dCA2 and dCA1 (known to process nonsocial odor-reward associations) in the TPP
odor task. I will also train multiple decoders to predict stimulus identity from 2-photon calcium imaging data,
looking for what kinds of stimuli are important to each region (social, nonsocial, rewarded, or nonrewarded odors)
based on decoder performance. Aim 3 examines an SZD genetic mouse model of the human 22q11.2 deletion
syndrome—Df(16)A+/- mice—which shows a profound deficit in social memory. In a second odor discrimination
pilot study, I found that Df(16)A+/- female mice resemble the performance of the CA2-silenced mice in their
impaired ability to distinguish between two social odors. Hence, I will use 2-photon imaging to compare CA2
responses to odor stimuli in this mouse model to that of their neurotypical cagemates. Furthermore, I will attempt
to rescue this social odor discrimination deficit with injection of a TREK-1 dominant-negative virus, which has
been shown to improve neuronal firing in the pathologically hyperpolarized CA2 neurons harbored by these
heterozygous mice. All in all, the results of my research will provide insight into how mice use sensory cues to
discriminate between social subjects and facilitate social recognition. My findings will initiate investigations into
how other social sensory modalities—like vision, hearing, and touch—are processed through CA2 in humans.

Public health relevance
PROJECT NARRATIVE In the short-term, my research on social odor encoding in the CA2 region of the hippocampus, and its comparison to CA1’s well-known function in odor processing, will uncover how murine animals form social memories by integrating and processing salient social cues. My parallel studies on rescuing social odor discrimination deficits in a mouse model of the human 22q11.2 Deletion Syndrome, in which social memory is impaired, will expose the purpose CA2 has in social cue consolidation and recall as well as its dysfunction in neuropsychiatric disease. In the long-term, my findings will initiate investigations into how odors and other social sensory inputs like vision, hearing, and touch are processed through CA2 in humans and why patients with Schizophrenia and other diseases with hallmark abnormalities in CA2 have difficulty recognizing familiar faces.